Immune Tolerance Network

Jane Hoyt Buckner, MD (Contact)
Mark S. Anderson, MD
NIDDK Supplemental Funding Request
5UM1AI109565-12
Project Summary / Abstract
The mission of the Immune Tolerance Network (ITN) is to advance the clinical applicaƟon of
immune tolerance by conducƟng high-quality clinical trials of emerging therapeuƟcs based on
testable mechanisƟc hypotheses. The ITN is designed to invesƟgate a range of diseases across
the immunologic spectrum through the integraƟon of innovaƟve clinical studies and cuƫng-
edge immunologic analyses.
Since its incepƟon, one of the areas of interest of the ITN has been Type 1 Diabetes (T1D) with a
focus to successfully enhance the development of tolerance therapies. We uƟlize a collaboraƟve
structure involving hundreds of invesƟgators, advisors, and clinical sites and mechanisƟc
laboratories working in tandem with a core group of ITN staﬀ, operaƟng a program that is both
scienƟﬁcally and ﬁnancially eﬃcient. Our intenƟon is to evolve our current strategies into the
next generaƟon of planned trials, as well as operate a ﬂexible, future-focused organizaƟon,
poised to lead and adopt innovaƟons.
Our approach—evaluaƟng novel tolerance therapeuƟcs in clinical seƫngs while simultaneously
invesƟgaƟng the geneƟc and immunologic mechanisms of disease and their response to
therapy—provides a robust framework for generaƟng cross-disease and cross-disciplinary
insights. This strategy is aimed at acceleraƟng the development of new therapeuƟc opƟons for
major diseases.
With lead insƟtuƟonal commitment from the Benaroya Research InsƟtute and the University of
California San Francisco, and parƟcipaƟon of more than 20 other major insƟtuƟons represented
in leadership and major advisory roles, the ITN strives to conƟnue to successfully pioneer high
impact clinical trials and mechanisƟc studies in T1D.

Public health relevance
Jane Hoyt Buckner, MD (Contact) Mark S. Anderson, MD NIDDK Supplemental Funding Request 5UM1AI109565-12 Project NarraƟve The proposed ITN UM1 funding addresses major unmet health needs. Over 15 million people, or 4.6% of the US populaƟon, have been diagnosed with an autoimmune disease, including T1D. Pre-clinical studies show that immune tolerance should be an achievable therapeuƟc prospect, and progress towards that goal is evident in recent clinical trials and the resulƟng mechanisƟc work. Successful tolerance oﬀers long-term freedom from immunosuppressive therapy, radically improving quality of life, disease burden, and health care costs.